Role of hypercapnia on the lung airways

Project Summary
Oxygen and nitric oxide activate cellular signaling pathways, which are important in lung health
and diseases. However, much less is known about the mechanisms by which lung cells (other
than carotid bodies) sense and respond to changes in carbon dioxide (CO2) concentrations. An
increase in the levels of CO2 (hypercapnia) is often a consequence of impaired gas exchange in
lung diseases such as chronic obstructive pulmonary disease (COPD) and others.
Approximately 17 million individuals in the US are afflicted by COPD, which now is the 3rd
leading cause of overall mortality worldwide. Several studies have reported that patients with
COPD and hypercapnia have worse outcomes. However, hypercapnia in patients with lung
diseases is largely tolerated as there is still the notion that the effects of hypercapnia are not
harmful to the lungs. Recent studies, including our own, have demonstrated that elevations in
CO2 activate specific intracellular signaling pathways with adverse consequences for lung and
organismal functions. We have conducted experiment using unbiased, hypotheses-generating,
as well as hypotheses-driven approaches, which have generated preliminary data on the effects
of hypercapnia on the lungs airways. Our preliminary results in preparation for this grant
application suggest that high CO2 levels activate specific signaling pathways leading to changes
in airway contractility. As such, we propose to elucidate the signaling pathways and
mechanisms by which hypercapnia increases airway contractility and smooth muscle cell
function via three interrelated specific aims. In experiments pertaining specific aim 1, we will
determine whether hypercapnia increases airway smooth muscle contraction via
activation of caspase-7 and downregulation of miR-133a-MEF2D. In studies pertaining
specific aim 2, we will determine whether hypercapnia increases actin polymerization
and thus airway smooth muscle contractility via RhoA and calcineurin and in studies
pertaining specific aim 3, we will determine hypercapnia promotes airway remodeling by
increasing αSMA and extracellular matrix via RhoA-SRF and/or Wnt-CTGF pathway.
Completion of the proposed experiments will provide novel information on signaling pathways
and mechanisms by which high CO2 levels lead to lung airways hyperreactivity, which is of
importance for patients with chronic lung diseases such as COPD and hypercapnia.

Public health relevance
Project Narrative High partial pressure of CO2 in blood (hypercapnia) is observed in patients with severe lung diseases such as bronchopulmonary dysplasia and chronic obstructive pulmonary disease (COPD). We propose experiments to determine the mechanisms by which high CO2 levels affects airway smooth muscle cells and thus lung airway contractility. The elucidation and new understanding of these mechanisms will serve to inform the effects of hypercapnia in patients with lung diseases and design potential novel therapies for patients with chronic lungs disease such as COPD.